Metabolism and HCMV: determinants of the antiviral state

Upon infection, numerous cell types secrete anti-viral cytokines that induce an anti-viral state in neighboring
cells, which is critical for limiting infection. This proposal focuses on two opposing aspects of this anti-viral
state: one, cytokine-induced metabolic reprogramming, which we find is essential for the ability of cytokines to
limit viral infection; and two, the Human Cytomegalovirus (HCMV) UL26 protein, which we find is a major
antagonist of anti-viral gene expression. HCMV is a major cause of congenital birth defects and causes severe
disease in several immunosuppressed patient populations. Our results indicate that the anti-viral cytokine
TNFα induces glycolytic activation, which is essential for its anti-HCMV activity. However, the mechanisms
involved are not clear. We propose to identify the mechanisms through which anti-viral cytokines induce
metabolic remodeling (Aim 1), and determine how cytokine-induced metabolic activities limit HCMV infection
(Aim 2). Finally, we will determine how the HCMV UL26 protein blocks anti-viral responses, which we
hypothesize involves modulation of the activity of an intrinsic immune transcription factor complex (Aim 3). The
proposed research will identify novel cellular and viral mechanisms that govern the success of HCMV infection.
These mechanisms represent key determinants that could potentially be targeted to limit virally-associated
pathogenesis.

Public health relevance
Human Cytomegalovirus (HCMV) is a major cause of permanent neuronal damage in thousands of infants in the United States every year and causes significant disease and death in individuals with weakened immune systems, including transplant recipients and some cancer patients. Cytokines are cellular signaling molecules that induce an anti-viral state to limit viral infection. Our proposal focuses on two opposing sides of the anti- viral state that could determine infectious outcomes: one, elucidating how cytokines reprogram metabolism to limit viral infection; and two, identifying the mechanisms through which the HCMV antagonizes anti-viral signaling.